Immunometabolism in Tissue Homeostasis and Diseases

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Immunometabolism in Tissue Homeostasis
and Diseases organized by Drs. Ping-Chih Ho, María Mittelbrunn and Stanley Huang, with scientific
programming input from Keystone Symposia. The meeting will take place February 10–13, 2025 at Keystone
Resort, Keystone, Colorado, USA.
Metabolic processes and enzymes provide regulatory circuits that tailor the behavior of immune cells in response
to local and systemic metabolic states. Recent progress in the field of immunometabolism has opened new
horizons and potential therapeutic strategies for diseases of aging, cancer and metabolism. Despite
immunometabolism being an interdisciplinary field that covers two main physiological parameters, immunity and
metabolism, our understanding remains largely restricted to the cellular and molecular levels. To facilitate the
translational impact of immunometabolism, this conference will bring together leading scientists in the areas of
aging, cardiovascular diseases, cancer and microbiome to extend insights from molecular and cellular studies
toward defining opportunities for unmet medical needs in the metabolic disease area that can be targeted with
immunometabolic interventions. Additionally, this meeting has been paired with another Keystone Symposia
conference, Trajectories to Heart Failure: Immunometabolic Mechanisms, to encourage the sharing of cross-
disciplinary insights among a broad range of investigators and support new collaborations geared toward
understanding the immunometabolic underpinnings of cardiovascular disease and identifying new therapeutic
approaches for these diseases through immune system modulation.

Public health relevance
PROJECT NARRATIVE The intersection of research in immunology and metabolism has led to the recognition that immunometabolic pathways have a fundamental role in influencing human health and disease. This Keystone Symposia conference features leading scientific discoveries by international thought leaders in the area and was designed to connect a cross-disciplinary community of researchers and encourage collaborations to gain deeper understanding of disease mechanisms and advance new treatment modalities that involve immune system conditioning. Additionally, this conference will be paired with a Keystone Symposia conference on Trajectories to Heart Failure: Immunometabolic Mechanisms to examine the influence of immune cell metabolism in cardiovascular disease and its potential for improving patient outcomes.